Lung Injury Biomarkers to Endotype Respiratory Trajectories in Established Bronchopulmonary Dysplasia: The LIBERATE-BPD Study

PROJECT SUMMARY/ABSTRACT: The purpose of this Mentored Patient-Oriented Research Career
Development Award (K23) is to provide Dr. Matthew J. Kielt, MD, Assistant Professor of Pediatrics at The Ohio
State University College of Medicine and Nationwide Children’s Hospital with the requisite mentorship, training,
and research experience to become an independent clinician-scientist with niche expertise in precision
medicine clinical trials. His long-term goal is to identify precision therapeutics that restore normal pulmonary
function in infants with bronchopulmonary dysplasia (BPD). His immediate goal is to develop the skills needed
to lead multi-center biomarker-driven clinical trials of anti-inflammatory therapeutics for infants with BPD. To
achieve these goals and transition to independence, Dr. Kielt and his mentorship team have developed a
comprehensive career development plan that includes: (1) intensive mentorship from an R01 funded team with
a proven record of K-award mentorship; (2) didactic and hands-on training in precision medicine research
methods, advanced longitudinal statistical analyses, and the conduct and design of clinical trials; and (3) an
innovative research proposal to develop biomarker-informed prognostic models for infants with BPD. Preterm
infants with the most severe form of BPD, grade 3, are ventilator-dependent near term corrected age and
suffer from chronic pulmonary insufficiency throughout life. Infants with grade 3 BPD exhibit striking
heterogeneity in the time required to wean from mechanical ventilation (MV). Infants with grade 3 BPD who are
difficult-to-wean from MV, defined as unsuccessful liberation from MV by 2 months’ corrected age, are at 3-fold
increased risk of death as compared to infants who are simple-to-wean. Biologic predictors that discriminate
grade 3 BPD infants who are and are not difficult-to-wean remain unknown. In adult critical care patients,
pathogenesis-informed biomarkers of lung inflammation discriminate patients who are and are not difficult-to-
wean. Additionally, biomarker-driven clinical trials in adults demonstrate that budesonide, an inhaled cortico-
steroid that reduces pulmonary inflammation, decreases the expression of pro-inflammatory biomarkers, and
facilitates weaning from MV. Whether these findings are generalizable to infants with grade 3 BPD constitutes
an important knowledge gap. Dr. Kielt's research proposal will address this knowledge gap by (1) determining
the discriminatory performance of pro -inflammatory biomarkers for grade 3 BPD infants who are and are not
difficult-to-wean from MV and (2) demonstrating the feasibility of a biomarker-driven clinical trial of budesonide
in infants with grade 3 BPD. The expected outcomes of Dr. Kielt's K23 studies will yield novel insights into
grade 3 BPD disease progression that will inform the design of pioneering R-series biomarker-driven
randomized controlled trials of anti-inflammatory therapeutics. His career development plan outlines a clear
path to gain the knowledge, skills, and experience needed to become an independent and innovative clinician-
scientist who leads multi-center BPD precision medicine clinical trials.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE STATEMENT: Bronchopulmonary dysplasia (BPD), the chronic lung disease of infancy, is the most common morbidity of preterm birth, results in lifelong respiratory impairment, and is a significant public health burden with no curative therapies. This proposal seeks to identify biomarkers of pulmonary inflammation that can be used to classify sub-populations of ventilator-dependent infants with BPD who are at the highest risk of experiencing adverse short-term outcomes including death and a prolonged need for mechanical ventilation. The results of this research will address critical knowledge gaps that impact BPD clinical care and drug discovery by identifying potential biologic targets that can be used to inform the design of precision medicine clinical trials for ventilator-dependent infants with BPD.